Provision of Phlebotomine Sand Flies for the NIAID Research Resources Repository

This agreement provides for the supply of sand fly larvae and adult flies to the research community via NIAID's Research Resources Repository.